Feasibility to develop a Black aging cohort in Southern California using SDOH

PROJECT SUMMARY
People who identify as Black American have higher rates of cognitive impairment, and are twice as likely to be
diagnosed with Alzheimer’s disease and related dementias (ADRD). However, Black communities have largely
been excluded from clinical trials and research studies delaying research progress of ADRD risk factors and
interventions. One area to improve participation in ADRD research and clinical trials from Black individuals is
community engagement. The goal of this R34 proposal is to generate socially- and culturally-aligned
approaches for successfully engaging Black communities in brain health research, and apply these techniques
to build a Black Aging Cohort in Southern California (Los Angeles County and Orange County). The approach
will utilize a mixed-methods research design (i.e., qualitative and quantitative) to identify structural and social
determinants of health (SDOH) that directly affect Black communities and the individualized neighborhoods
they reside in, and how these factors impact their willingness to participate in ADRD research studies and
clinical trials. First, we plan to identify and engage stakeholders in Los Angeles County and Orange County to
share and align health equity strategies for brain health. The goal of these relationships is to develop citizen
panels (a small set of community stakeholders who possess a knowledge of community contexts) and a
community equity board (community members who represent the community) who we can collaborate with to
build awareness and understanding of brain health in the community and develop best practices for community
engagement. Second, we will utilize existing online databases and tools to assess SDOH that are directly
impacting Black neighborhoods. This research will provide census- and government-based indicators of
structural factors and SDOH that may be barriers for research participation. Finally, we will conduct focus
groups to determine SDOH barriers and facilitators that relate to participation in ADRD research and/or clinical
trial studies. This aim will provide direct perspectives from Black American residents about available resources,
the inequalities currently impacting their neighborhood, and how they affect their health and ability to
participate in research. Focus group findings will provide context for identified structural factors and SDOH
identified from the Citizen Panels, community equity boards, and online databases. Completion of these aims
will generate neighborhood-specific, culturally tailored community engagement practices to further enhance our
relationships with Black communities. Sustained relationships will further help the investigators develop a
community informed health equity research plan for a future R01 application.

Public health relevance
PROJECT NARRATIVE Black communities are at higher risk for cognitive impairment and Alzheimer’s disease and related dementias (ADRDs), yet this group is largely underrepresented in research and clinical trial studies. This project aims to generate culturally tailored approaches for successfully engaging the Black community in brain health research. Findings from this project will help inform best community engagement practices to build a Black Aging Cohort in Southern California.